Mechanistic Impact of PI3K/mTOR Signaling on Intestinal Homeostasis

The mammalian intestinal mucosa undergoes a process of continual renewal characterized by active
proliferation of stem cells localized near the base of the crypts; progression of these cells up the crypt-villus
axis with cessation of proliferation; and subsequent differentiation into one of the four primary cell types (i.e.,
enterocytes, goblet cells, Paneth cells and enteroendocrine cells). An imbalance in this highly-regimented and
orderly process within the crypts is associated with a number of common intestinal pathologies (e.g., colorectal
cancer and inflammatory bowel disease [IBD]). Delineating the molecular factors regulating intestinal
proliferation and differentiation is crucial to our understanding of not only normal gut development and
adaptation, but also aberrant gut growth. With the support of this grant, we have shown the importance of the
PI3K/Akt/mTOR and Wnt/β-catenin pathways in the regulation of intestinal cell proliferation and differentiation.
In addition, we showed that enhanced ketogenesis by mTORC1 inhibition contributes to the regulation of
intestinal cell differentiation and that tuberous sclerosis complex 2/mTORC1 signaling contributes to the
maintenance of intestinal epithelial homeostasis. Moreover, we found that activation of Wnt/β-catenin signaling
suppresses the expression of the ketogenic enzyme hydroxymethylglutaryl CoA synthase 2 (HMGCS2), which
inhibits glycolysis in intestinal cells. Recently, we have shown that deficiency of SIRT2, a member of the sirtuin
family of proteins, results in the activation of Akt/mTORC1 and Wnt/β-catenin, increased intestinal cell
proliferation and stemness, and increased expression of glycolytic hexokinases (HK) 1 and 2. Using single cell
sequencing, we found that HK1 and HK2 were differentially expressed in various types of intestinal cells;
knockdown of HK2, but not HK1, increased Paneth and goblet cell differentiation. Based on our recently
published and preliminary findings, we have further refined our central hypothesis to state that the glycolytic
enzyme HK2, acting downstream of SIRT2, significantly contributes to the maintenance of normal intestinal
homeostasis. To examine our central hypothesis, we have planned experiments with the following Specific
Aims: 1) to further delineate the cellular mechanisms for SIRT2-mediated alterations of glycolysis and
oxidative phosphorylation in intestinal cells; 2) to better define the role of HK2 in mediating the effects of SIRT2
in the intestine; and, 3) to determine the impact of alterations of SIRT2/HK2 on intestinal homeostasis in vivo.
The studies in the current proposal represent direct and novel extensions of our previous findings, and are
designed to define, in a systematic fashion, the molecular mechanisms and signaling events regulating the
processes of intestinal proliferation, differentiation, and adaptation utilizing a number of innovative techniques
including murine and human intestinal organoids, novel transgenic models, single-cell sequencing, and stable
isotope resolved metabolomics (SIRM).

Public health relevance
Narrative The intestinal mucosa is in a constant state of growth and renewal; the molecular pathways contributing to this tightly-controlled and highly-regimented process remain to be completely elucidated. Our recent findings have identified the glycolytic enzyme, hexokinase 2 (HK2), acting downstream of SIRT2, as a critical factor in the maintenance of normal gut growth and differentiation. Delineating the cellular factors regulating these normal processes is crucial to our understanding of normal gut development and maturation and also various intestinal pathologies (e.g., inflammation) that can arise from deregulation of these pathways.